Paneth cell plasticity and regeneration

ABSTRACT
Impaired intestinal epithelial healing can contribute to chronic inflammation in inflammatory bowel disease (IBD).
Current IBD therapies target the immune response without addressing intestinal epithelial repair defects, which
may contribute to risk of relapse in patients with IBD. Studying intestinal epithelial repair will lead to a better
understanding of IBD pathogenesis as well as novel therapies that may be more effective than current therapies.
Intestinal epithelial homeostasis is maintained by adult stem cells that reside at the base of the crypt. When
these stem cells are injured or depleted, other differentiated cells in the epithelium, specifically secretory cells,
can de-differentiate and replenish the epithelium. A specific secretory cell type, Paneth cells, are found at the
base of the crypt intercalated between the stem cells, putting them in a prime location to replace stem cells when
they are ablated. However, mechanisms of Paneth cell plasticity are unknown. Our lab recently showed that cells
with high autophagic vesicle content were identified as having stem-like capacity via their ability to generate
organoids after being seeded as single cells. These findings and other studies showing that autophagy is
necessary for the intestinal epithelium to recover after injury, suggest that autophagy may play an important role
in this de-differentiation process. Additionally, recent studies have shown that after injury, the intestinal
epithelium upregulates fetal-like reversion genes and no longer expresses differentiated cell genes, suggesting
a reversion to a more plastic and undifferentiated state. Though both autophagy and fetal-like reversion have
been suggested to be mechanisms for de-differentiation, it is not clear whether these two processes are related.
Therefore, I hypothesize that Paneth cells require autophagy to transition through a fetal-like state to de-
differentiate following epithelial tissue injury. In Aim 1, I will determine if autophagy is necessary for Paneth
cells to de-differentiate. In Aim 2, I will test whether the increase in organoid formation from Paneth cells with
high autophagic vesicle content is due to an increased ability to upregulate fetal-like reversion genes through
YAP signaling. These aims will define a role for autophagy in Paneth cell plasticity and whether expression of
fetal-like reversion genes contribute to this process. This work will provide a basis for understanding why patients
with IBD have impaired epithelial healing and may lead to novel therapeutics focusing on epithelial cell
autophagy.

Public health relevance
PROJECT NARRATIVE Inflammatory bowel disease (IBD) is characterized by chronic inflammation of the digestive tract and though there are treatments for IBD, there are currently no cures. This proposal aims to define how certain cells of the intestinal epithelium help repair tissue injury using mouse and organoid models. Findings from this work may identify novel pathways to new therapies for healing the intestinal epithelium in patients with IBD.